Multidisciplinary Training in Substance Abuse Research

Project Summary
This is a resubmission of a T32 training grant from the University of Miami, Miller school of Medicine aimed at
training pre- and post-doctoral trainees in drug abuse research. Our program's goal is to train both basic
scientists and clinicians to better understand the basic science concepts underlying substance abuse and to
translate the findings made “at the bench” to inform clinical practices at the “bedside”. With the alarming
increase in the abuse of prescription opioids it is imperative to understand the mechanisms underlying drug
abuse at a multidisciplinary level to improve evidence-based and formulate effective treatments for patients
with addictive disorders. Our overall goal is to provide trainees with professional skills to pursue productive
academic careers in drug abuse research. Primary objectives of this program include: 1) provide trainees with
either a rigorous laboratory research experience or patient- or population-oriented research experience in
substance abuse research by linking promising candidates with outstanding mentors who are meticulously
selected based on scientific qualifications and experience in drug abuse training; 2) to provide trainees with
essential research skills and information regarding career development in substance abuse research through
structured course work, lectures and seminars, which emphasizes training in ethics and scientific integrity
academic "survival skills," specific research tools and exposure to diverse research methodologies; 3) to
enhance and teach skills in mentorship to junior faculty through active co-mentoring of trainees with senior
faculty with a formal training program. This program will include outstanding mentors who, in addition to
success in their focused areas of research, are committed to teaching broad research skills, such as
performing scholarly reviews of the literature; formulating hypotheses and study design; developing essential
skills in statistics, oral and written presentation of scientific findings and grant writing; understanding issues and
defining potential problems of scientific integrity and ethics. The program leadership will further ensure close
monitoring of trainee progress. Our team of experienced mentors with active, external peer-reviewed funding
are committed to the highest quality research experience, providing state of art training in substance abuse
research. The proposed program incorporates a comprehensive training plan in the responsible conduct of
research and promotes diversity by recruiting and retaining women, and minority candidates. The University of
Miami offers a dynamic, stimulating and collegial learning environment for this training mechanism.

Public health relevance
Project Narrative The objective of this training grant is to train the future generation of researchers to better understand the basic science concepts underlying substance abuse and its associated comorbidities and to translate these findings for more effective therapeutic interventions at the “bedside”. Trainees on completion of the program will be better prepared to take on the challenges affecting the health of millions of drug abusing individuals, their families and all society who currently spend billions of dollars a year on this medical and social problem.